PRANAYAMA BASED MOBILE APP FOR BREAST CANCER SURVIVORSHIP: I-CORPS SUPPLEMENT

PROJECT SUMMARY
Cancer remains the second leading cause of deaths in the U.S. Encouragingly, recent improvements in early
diagnosis and treatment has led to significant increases in the survival rate of cancer patients. As cancer
becomes a chronic but manageable disease for thousands of survivors, the long-term physical and psychological
side effects of treatment protocols is becoming more apparent, as is the impact of these issues on disease-free
or overall survival. As a result of this changing landscape, survivorship care programs and approaches that
incorporate non-pharmacological lifestyle and mind-body interventions are becoming increasingly critical
components of the patient treatment pathway. In this regard, integrative approaches such as yogic breathing
(YB), a collection of techniques to voluntarily regulate breathing, have emerged as an effective complementary
therapy for cancer patients. YB is well-established to induce strong relaxation responses via vagal and
parasympathetic stimulation. YB is easy to practice using virtual tools such as mobile apps especially during the
current scenario of COVID-19 pandemic and social distancing. In this application, PranaScience seeks to
develop a novel group video app for YB that is optimized for home-based delivery of a proscribed YB program
that is maximally effective in promoting peer support, and relieving symptomatic conditions associated with
cancer treatment and survivorship. This intervention is based on compelling preliminary data generated by the
PI of this proposal demonstrating that specific YB exercises induce alterations in the levels of proteins associated
with tumor suppression, immune regulation, neuromodulation, and stress response/ inflammation, as well as
pilot studies performed in cancer survivors and other patient/general populations indicating that participants are
interested in a YB intervention and perceive improvements in well-being after YB sessions. In this Phase I STTR,
PranaScience (1) has built a first production version of a culturally neutral group video YB app and (2) partners
with the Medical University of South Carolina (MUSC) to pilot test the YB app in breast cancer survivors to
evaluate adherence, feasibility, and acceptability of the app to support symptom management. App usage data
is collected and used to evaluate adherence to the program, and acceptability for symptom management will be
evaluated using a series of defined biobehavioral measures at baseline and following a 12-week implementation
period. Exploratory salivary and fingernail biomarker analysis focused on tumor suppressors, inflammatory
cytokines, proteome level alterations, and stress hormones will be performed at baseline and at week 12.
Structured, focus group interviews of study participants will be used to assess technology perception/ program
feasibility and will inform future design optimizations. Information from the I-Corps supplemental work will be
used to refine app in preparation for large-scale evaluation in Phase II, and for commercialization purposes
through customer discovery interviews.

Public health relevance
NARRATIVE Cancer survivorship is associated with many long-term chronic health issues that arise as a result of cancer treatment protocols. Non-pharmacological lifestyle and mind-body interventions have been shown to be effective and critical components of a total-health strategy for cancer survivors. PranaScience Institute has developed a novel group video app for home-based delivery of a Yogic Breathing intervention and would like to study its marketability and commercialization potential through this I-Corps supplemental funding.